Targeting Mutant IDH1 for a Novel Synthetic Lethal Interaction in Malignant Gliomas

Project Summary:
Glioblastoma multiforme (GBM) is the most common primary brain tumor with about
8500 cases diagnosed each year in the United States. Within a time frame of 15 month
virtually all patients succumb to this detrimental disease despite treatment efforts.
Therefore, novel, ideally tumor specific approaches are necessary to combat these
tumors. While single reagents may efficiently target other tumors, such as hematological
malignancies, Glioblastoma is strikingly different since it is a tumor that is characterized
by extensive heterogeneity, demanding the simultaneous inhibition of ideally several
deregulated pathways. Our previous research has shown that targeting tumor
mitochondria for cancer therapy causes significant anti-glioma effects, especially when
used in combination therapies. In this proposal, an accomplished team of investigators
will be characterizing a novel treatment concept for glioblastoma by causing tumor-cell
specific cell death through induction of synthetic lethality in IDH1 mutated GBMs. In the
first aim, we will dissect the most proximal effect of mutant IDH1 and 2-HG, involving
tumor cell metabolism that finally renders tumors susceptible to Bcl-xL inhibition
mediated apoptosis. In the second aim, we will test as to whether interference with anti-
apoptotic Bcl-2 family members along with 2-HG results in an integrated stress response
with an Activating Transcription Factor 4 (ATF4) mediated increase of Noxa, which in
turn antagonizes Mcl-1 and primes tumor cells to apoptosis. In the third aim, we will
assess as to whether the IDH1 mutations are synthetically lethal with tumor mitochondria
targeting drugs and extend animal survival in disease-relevant animal models of glioma.
Overall, our research may help to provide more specific and efficient treatments for
patients suffering from GBM. Overall, this research may enhance our understanding
about the treatment of brain tumors and may potentially allow us to formulate a novel
treatment strategy for secondary glioblastoma and other gliomas.

Public health relevance
Narrative: Glioblastoma multiforme (GBM) and high-grade gliomas are the most common primary malignant brain tumor in adults with a grim prognosis after diagnosis. Therefore, novel treatment concepts need to be identified. The current proposal explores an innovative, unique therapeutic approach that causes tumor cell death by targeting aspecific metabolic alterations found in tumor cells with a distinct mutation. In certain gliomas, this mutation is present in up to 90% of cases. This treatment approach displays anti-tumor effects on GBM and glioma cells in vitro and in vivo without causing significant side effects. If successful this proposal may set the stage for a novel tumor specific treatment concept that ultimately may allow helping patients suffering from this detrimental disease.